Brain estrogen as a regulator of post-menopausal VCID

Project Summary/Abstract
The vast majority of women who have dementia are also post-menopausal. Following menopause, women
become more susceptible to risk factors for VCID (vascular contributions to cognitive impairment and
dementia). This effect could be mediated by the plummet in gonadal production of estrogen, a hormone that
has been shown to be protective against both VCID risk factors and cerebrovascular dysfunction. The effect of
estrogen on cognitive impairment in post-menopausal VCID is unknown. Little is known about the mechanisms
through which menopause and diminished ovarian estradiol production produce this altered state of VCID risk,
leaving opportunities to preserve cognitive function of post-menopausal women underutilized. Post-
menopausal estrogen production can still occur through the actions of the enzyme aromatase in a variety of
non-gonadal tissues, including the brain. We have previously shown aromatase to be critical for endothelial
dependent vasodilation in female mice. Endothelial cells have many vital functions in the brain: forming the
blood brain barrier and protecting the highly regulated brain environment from exposure to blood proteins and
peripheral immune cells. Blood brain barrier disruption is associated with cognitive impairment in both humans
and rodents. The permeability of the blood brain barrier is sensitive to the effects of estrogen and therefore
could be influenced by menopause. If blood brain barrier permeability is increased by menopause, it could be a
mechanistic link between menopause and cognitive impairment in VCID. In this work, I ask if endothelial and
gonadal estradiol production impacts cognitive impairment in VCID, if these effects could be related to changes
in blood brain barrier function, and if intraventricular estradiol delivery could have an ameliorative effect on
post-menopausal VCID. I will address these questions in three aims. In Aim 1, I will investigate the effects of
menopause on VCID in mice by inducing menopause using an ovary-intact method (4-vinylcyclohexene
diepoxide). I will use a unilateral carotid artery occlusion surgery to model chronic cerebral hypoperfusion. I will
perform behavior testing to assess cognitive deficits and I will compare blood brain barrier permeability and
inflammation as candidates to contribute to pathological differences between groups. In Aim 2, I will determine
if abolishing endothelial estradiol production by knocking out aromatase specifically in endothelial cells
worsens cognitive impairment and pathology in post-menopausal VCID. To do this, I will use our endothelial
specific aromatase knock out mice. In Aim 3, I will determine if I can protect against the negative effects of our
interventions on cognitive function by specifically delivering estradiol to the intraventricular space in the brain.
Funding from this grant will allow me the opportunity to investigate these questions, will facilitate my training
and development as a scientist, and will potentially contribute to the prevention and treatment of cognitive
impairment in post-menopausal women with VCID.

Public health relevance
Project Narrative VCID (vascular contributions to cognitive impairment and dementia) risk factors increase in women after menopause, a period in which gonadal estrogen production diminishes. Estrogen, which can also be produced by endothelial cells, has been shown to improve cerebrovascular endothelial function and protect against VCID risk factors. This project will investigate the role of both gonadal and endothelial estradiol production and how that relates to cognitive impairment in VCID, potentially exposing opportunities for therapeutic intervention.